Core A-Administrative Core

PROJECT SUMMARY – Administrative Core (A)
The NIH has made substantial research investments in response to the large burden of musculoskeletal
diseases in the United States. The Washington University Resource-Based Center for Musculoskeletal
Biology and Medicine was formed to enhance NIH-funded, musculoskeletal research on our campus, with a
focus on basic and pre-clinical research. We have achieved a positive impact through efficient delivery of
essential and rigorous research services and a strong enrichment program. In the past 4 years the P30
Center Grant (AR074992) has been linked to 237 publications that have generated more than 3,000
citations. We now seek to maintain our local impact while we extend our programs to researchers at other
institutions. The Administrative Core will lead the Center, under the direction of Matthew Silva (Director) and
Deborah Veis, Roberto Civitelli and Roberta Faccio (Associate Directors). We bring extensive leadership
experience along with a history of collaboration and commitment to musculoskeletal research at
Washington University (WashU). We represent a Research Community of 97 investigators: 85 WashU
faculty plus 12 Affiliate faculty from other institutions. We propose four Aims. Aim 1: Provide leadership of
the Center through a transparent organizational structure. We will coordinate interactions with an Advisory
Board, and collaborate with other WashU Centers and Programs to promote musculoskeletal research. We
will lead outreach activities to introduce students to musculoskeletal science and promote diversity, equity
and inclusiveness. Aim 2: Promote, manage and evaluate the Center and its three Resource Cores. We will
provide oversight of the Research Cores to ensure that they are accessible, efficient and state-of-the-art.
Through regular evaluation of utilization and performance, we will ensure that the Resource Cores have
strong impact locally and nationally. Aim 3: Communicate with stakeholders and increase outreach and
recruitment of Affiliate Members from nearby states who will strengthen our Center. We will advertise
Center resources, events, news, and opportunities, to members of the Research Community and beyond,
via multimedia communications. Aim 4: Administer the Enrichment Program. We will administer the Pilot &
Feasibility Grant Program to support promising studies that build toward extramural grants by early-career
investigators and those new to musculoskeletal research. We will organize weekly seminars, and an Annual
Research Symposium to highlight the work of the Research Community and provide training and
enrichment opportunities to our members. Through these Aims, we will accelerate, enrich, and enhance the
effectiveness of basic and pre-clinical musculoskeletal research at WashU and at other institutions.